in Vitro ADME Screening and Support of Novel Therapeutics

The Division of Cancer Treatment and Diagnosis (DCTD) takes prospective detection and treatment leads, facilitates their paths to clinical application, and expedites the initial and subsequent large-scale testing of new agents, biomarkers, imaging tests, and other therapeutic interventions (radiation, surgery, immunotherapy) in patients. The Developmental Therapeutics Program serves as a vital resource in discovering potential cancer therapeutics and acquiring preclinical development information. The program provides research materials and manufactures new agents in bulk quantities for use in investigational new drug (IND)-directed studies.